The role of LDTg to VTA calcitonin receptor signaling in the control of food reward

Project Summary: Amylin signaling decreases food intake and gastric emptying in both humans and rats via
activation of CNS amylin receptors (calcitonin receptor, CTR; heterodimerized with a receptor activating modified
protein, RAMP1-3) making it a potential target for the development of novel pharmacotherapies to treat obesity.
Despite the distributed nature of CNS amylin receptors, research on the role of amylin signaling in the control of
energy balance has been largely focused on hypothalamic and hindbrain nuclei, leaving other nuclei with
abundant CTR expression such as the mesopontine laterodorsal tegmental nucleus (LDTg) understudied.
Recent work from our lab showed that LDTg CTR signaling reduces food intake. Additionally, in the absence of
endogenous LDTg CTR signaling, rats show increased food intake and body weight gain. However, the
mechanism by which CTR signaling in the LDTg modulates energy balance, as well as the downstream nuclei
targeted by LDTg CTR expressing neurons (LDTgCTR) has not been explored. The LDTg is known to modulate
dopamine signaling to regulate motivated behavior via direct projections to the ventral tegmental area (VTA) and
our preliminary data shows that several LDTgCTR neurons send direct projections to the VTA. Consequently, we
will use chemogenetics to activate LDTgCTR neurons that project to the VTA and evaluate the effect of this
manipulation on feeding and motivation to obtain palatable food rewards (Aim 1). We will also use a dual AAV
approach to projection-specifically knockdown CTR expression in LDTg neurons that project to the VTA and
evaluate the role of these neuron’s endogenous CTR activity in the regulation of energy balance and palatable
food reward seeking motivation (Aim 2). Lastly, we will use fiber photometry to monitor the activity of LDTgCTR
neurons in lean and obese animals in response to food availability at different energetic states. Then, we will
determine how diet-induced obesity affects the ability of LDTgCTR neurons to modulate downstream VTA
dopaminergic (VTATH) neurons (Aim 3). Altogether, we hypothesize that this novel mesopontine-limbic signaling
pathway will have the ability to reduce food intake and body weight without inducing symptoms of malaise, via
modulation of downstream VTATH neurons. Consequently, the proposed work will functionally characterize a
promising target for the development of effective obesity pharmacotherapies.

Public health relevance
Project Narrative: Obesity in the United States has become a grave public health threat, highlighting the need for the development of more effective obesity treatments. Understanding how gastrointestinal-derived satiation signals, such as amylin, affect neuronal activity to control feeding behavior is necessary for the development of novel pharmacotherapies to combat obesity. The proposed work will evaluate the role of amylin receptor signaling in a novel mesopontine-limbic pathway in the regulation of food intake and motivation to seek palatable food rewards.